Mitochondrial inheritance and quality control

Protein homeostasis, or proteostasis, relies on precise control of protein synthesis, folding and degradation.
Proteostatic errors lead to protein aggregates, which are toxic and linked to neurodegenerative, cardiovascular,
muscular and metabolic disorders, and to premature aging. The ER and mitochondria are major sites for protein
folding and are supported by quality control mechanisms that correct protein folding or eliminate proteins or
organelles that are damaged beyond repair. ER-associated degradation (ERAD) and mitochondria-associated
degradation (MAD) are functionally and mechanistically related mechanisms. In both, misfolded proteins are
identified, ubiquitinated, extracted from organelles and degraded by the proteasome. However, both pathways
have limitations. Previous studies suggested that MAD proteostasis was restricted to mitochondrial outer mem-
brane (OM) proteins, <10% of mitochondrial proteins. Moreover, MAD and ERAD are inherently low-throughput
because they act on individual proteins. Our R35-funded research revealed that 1) MAD plays a major role in
mitochondrial and cellular fitness in a model for aging, 2) loss of MAD function results in premature aging, and
3) MAD functions in proteostatic control not just in the mitochondrial outer membrane, but also in the matrix and
inner membrane of the organelle. In complementary studies, we identified a conserved ER proteostasis pathway
(ER-PERM) that has overlapping function with ERAD, but has higher throughput and contributes to the ER stress
response in yeast, mammalian cells and cellu models for a newly identified congenital muscular dystrophy
(CHKB CMD). In ER-PERM, lipid droplets (LDs), organelles that form at ER membranes, act as escape hatches
for large-scale removal of unfolded ER proteins and degradation of those proteins and their LD carriers. Here,
degradation occurs by microautophagy, a conserved but understudied form of autophagy that does not rely on
autophagosomes or core ATG genes for delivery of cargoes to the vacuole (yeast lysosome). Important future
goals are to 1) understand the mechanism of MAD function within mitochondria, 2) the physiological conse-
quences of MAD-mediated mitochondrial proteostasis, and 3) identify components and functional consequences
of ER-PERM. We request funds to replace a broken, unrepairable, >15 year-old microplate reader (Tecan
NanoQuant) that was heavily used for assays that are essential to the completion of our R-35-funded research
including yeast growth curves, protein and nucleic acid determination, enzyme assays, and screening for
expression of fluorescence tags on proteins of interest. While there are plate readers in other labs or equipment
cores, those instruments are not available for long-term, uninterrupted use like analysis of yeast growth curve or
any growth-based screens (350 hrs/month). Thus, we request funds to purchase a new plate reader (Tecan
Infinite Base Unit, M200 and F200 PRO Microplate Reader) and the computer hardware and software to drive
the plate reader.

Public health relevance
Narrative Accumulation of unfolded proteins results in cellular dysfunction and premature aging, and is linked to neurodegenerative, cardiovascular, muscle and metabolic disorders. We request funds to replace a >15-year- old instrument is that is essential for completion of our NIH-funded studies on the mechanism of action of existing and newly identified protein quality control mechanisms that identify and eliminate unfolded proteins within cells.